Malaria: Mechanisms of Immunity & Protection

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Malaria: Mechanisms of Immunity &
Protection, organized by Drs. Silvia Portugal, Marion Pepper and Melissa Chola Kapulu, with scientific
programming input from Keystone Symposia. The meeting will take place March 30–April 2, 2025 at the
Eldorado Hotel & Spa in Santa Fe, New Mexico.
Progress against malaria remains a worldwide challenge, and a renewed combination of innovative approaches,
including novel research and implementation strategies, are needed to tackle this global health problem. This
Keystone Symposia conference will highlight emerging scientific discoveries, methods development and clinical
practice approaches to empower research. Specifically, the program will review central immunologic principles
to combat malaria by integrating mechanistic and clinical research advances, and will include discussions of new
insights into immune protection against severe malaria; explore how clinical immunity against mild malaria
develops over the course of repeated infections; highlight emerging data from the latest next generation vaccines
trials; examine passive immunization approaches or drug administration to induce naturally acquired immunity
to malaria; and integrate multiomics and modeling approaches to better understand both the natural development
of immunity and the impact of interventions. The scientific focus of this conference directly addresses the need
for innovative approaches to malaria prevention and treatment and will emphasize scientific discovery and new
public health strategies for effective malaria control and prevention measures. Additionally, this meeting will serve
as an educational forum to update researchers, healthcare professionals, and policymakers on the latest
developments in malaria research.

Public health relevance
PROJECT NARRATIVE Despite research progress over decades, malaria remains a persistent global health challenge, which requires that the research community come together to share new discoveries and evaluate recent successes and failures in prevention, therapeutics and public health approaches to define a more effective strategy to address malaria infections worldwide. This conference program will bring together an international community of malaria researchers to discuss the ongoing and future focus of research and implementation campaigns to tackle this ongoing global health problem. Attendees at this meeting will learn about the latest tools, research methodologies and developments in malaria immunity and immunization strategies to drive new, innovative approaches that may be harnessed to benefit populations affected by malaria.